VITAMIN INTERVENTION FOR STROKE PREVENTION (VISP)

This multi-center, double-blind, randomized, controlled clinical trial has been designed to determine whether the addition of a multi-vitamin with high dose folic acid, pyridoxine (vitamin B6) and cyanocobalimin (vitamin B12) to best medical/surgical management and risk modification reduces recurrent cerebral infarction (primary endpoint) and myocardial infarction or fatal coronary heart disease (CHD, secondary endpoint) in patients with a non-disabling cerebral infarction (NDCI) who have basal homocyst(e)ine levels above 9.5 umol/L at screening. The fundamental eligivility criteria are the occurrence of a NDCI within 120 days prior to randomization and a qualifying homocyst(e)ine level. All patients will receive best management for risk factor reduction, which includes counseling and interventions for hypertension, high LDL (low-density lipoprotein), low HDL (high-density lipoprotein), tobacco use, diabetes and other recognized factors which add excess risk for cerebral and myocardial infarction. The study is designed to recruit 3600 patients (1800 in each of two groups) for 80% power for detection of a 30% treatment effect, allowing for 20% non-compliance in the high-dose treament group. Each patient will be on study for 2 years.